Human and Population Research Core

PROJECT SUMMARY: Kristen Pierce, MD, HPR Core (Research Core 1)
The Human and Population Research (HPR) Core is an academic accelerator for clinical, translational, and
public health research dedicated to decreasing the morbidity and mortality caused by global infectious
diseases. HPR Core objectives are to support the development of our next generation of scientists and their
research projects, and to expand our institution-wide strength in global infectious disease research. By offering
a suite of expertise in a single core, the TGIR COBRE's HPR Core is designed to address expertise gaps,
diminish roadblocks, and facilitate the conduct of high-quality clinical, translational, and public health research.
The HPR Core provides education and four key services: a) Research Navigator, b) Biostatistics services, c)
Data Management, and d) Biorepository and Specimen Management. A key feature of the HPR Core is its
Research Navigator component, which coordinates with the entire team to advise, train, and support our junior
investigators in the development and execution of new research initiatives in clinical and translational research.
The Core is directed by senior clinical investigator Professor Kristen Pierce, MD, alongside a highly
experienced team with expertise in study design and management, regulatory and ethical standards, statistics,
data management, as well as specimen management/biorepository services. Educational opportunities for our
junior faculty include our Clinical Researcher Training Program (CRTP), core curricula in the design and
conduct of clinical research, and a rotating series of training “bootcamps” for building specific skills. In Phase 1,
the HPR Core supported 22 projects led by our junior faculty, and continued growth is anticipated. In Phase 2,
the Core will add a co-investigator to lead opportunities based on our biorepository services update our RN
services to better support our developing junior faculty. The core will continue to expand its institutional
footprint, complement the COBRE’s Mathematical and Computational Predictive (MCP) Modeling Core, and
extend our educational and training programs, including the CTRP.